The Oncogenic functions of YAP/TAZ in Renal Cell Carcinoma

PROJECT ABSTRACT
Renal cell carcinoma (RCC) is the 8th most common form of adult cancer in the US. Despite recent
improvement in treatment options, the majority of patients with metastatic RCC continue to succumb to this
disease, resulting in over 100,000 deaths per year worldwide. Thus, it is important to identify novel therapeutic
strategies to more effectively treat this deadly disease. My preliminary studies suggest that YAP/TAZ function
as master regulators of the core oncogenic transcriptional network and are required for maintaining the
transcriptional homeostasis of RCC tumors. The first major aim of my proposal is to determine the effects of
pharmacologic and genetic inhibition of YAP/TAZ on oncogenic transcription and super enhancer maintenance
in patient-derived primary RCC cells. I will employ cutting-edge epigenomic techniques including Cut&Tag and
QuantSeq to probe how genetic and pharmacological inhibition of YAP/TAZ affects the compositions and
activities of the YAP/TAZ transcriptional complexes and the global RCC epigenetic and transcriptional
landscape. Given the reported functions of YAP/TAZ in orchestrating phase-separated transcriptional
condensates at super enhancers, I will combine immunofluorescence analysis of endogenous YAP/TAZ and
other components of the YAP/TAZ transcriptional complexes, along with DNA fluorescent in situ hybridization
(DNA-FISH) against YAP/TAZ-bound enhancer regions, to investigate how genetic or pharmacological
inhibition of YAP/TAZ affects the formation of active transcriptional condensates at these particular genetic
elements and their necessity in regulating YAP/TAZ target genes. Through these analyses, I will be able to
gain critical insights into the molecular functions of YAP/TAZ in RCC tumors, but also reconstruct the core
ensemble of the RCC oncogenic transcriptional network. The second major aim of this proposal is to determine
how YAP/TAZ functionally interacts with hypoxia-inducible factor 2 alpha (HIF2A) and whether YAP/TAZ co-
inhibition can overcome resistance to HIF2A inhibitors in an in vivo model. While HIF2A inhibitors are in late
stage clinical trials, upfront and acquired resistance to this small molecule inhibitor is prevalent. My preliminary
findings suggest that YAP/TAZ signaling may contribute to resistance to HIF2A inhibitors. Using
pharmacological inhibitors of YAP/TAZ and HIF2A, I intend to use Cut&Tag and QuantSeq to investigate the
functional interactions between HIF2A and YAP/TAZ in maintaining clear cell RCC oncogenic transcription, as
well as possible YAP/TAZ regulated genes mediating resistance to HIF2A inhibitors. Furthermore, I will
investigate how YAP/TAZ inhibitors, in combination with HIF2A inhibitors, impact the in vivo growth of HIF2A-i-
resistant patient-derived ccRCC xenografts, performing QuantSeq on harvested tumors to validate my in vitro
findings. Together, these studies will greatly enhance our understanding of the crosstalk and redundancies
between the oncogenic pathways that govern the growth and survival of RCC cells, potentially yielding more
effective combination strategies to overcome treatment resistance in RCC patients.

Public health relevance
PROJECT NARRATIVE Renal cell carcinoma (RCC), the 8th most common form of adult cancer in the US, is in need of novel therapeutic strategies to overcome resistance to existing therapies. My preliminary studies have revealed that deregulation of the Hippo-YAP/TAZ pathway represents a major molecular hallmark in RCC, and is a key mechanism used by RCC cells to maintain their transcriptional homeostasis. Employing patient-derived RCC tumor models and clinically viable inhibitors, my study will establish the therapeutic potential and mechanisms of actions for YAP/TAZ-based therapies in RCC.